Social phobia and cigarette smoking: An experimental investigation

DESCRIPTION (provided by applicant): Cigarette smoking is a prevalent and costly behavior that is estimated to kill over 440,000 people in the United States every year (CDC, 2008a). Rates of cigarette smoking are particularly elevated among individuals with psychopathology (CDC, 2008a). Within this category of individuals with psychopathology, individuals with Social Phobia (SP) represent a large group with elevated rates of cigarette smoking who quit smoking at rates lower than that of individuals without psychopathology (Lasser et al., 2000; Ruscio et al., 2008). These findings highlight cigarette smokers with SP as a particularly important group for further examination. For individuals with SP, cigarette smoking may be used to reduce feelings of social anxiety in anticipation of and during social situations and may also be used to increase contact with other smokers (McCabe et al., 2004; Wittchen, Stein, & Kessler, 1999). Two existing prospective longitudinal studies suggest that a relationship between SP and cigarette smoking exists and that this relationship may be temporal in nature such that SP and SP symptoms predict the onset of nicotine dependence (Breslau, Novak, & Kessler, 2004; Sonntag et al., 2000). Despite this relationship, no studies to date have experimentally examined the functional relationship between SP and cigarette smoking in order to determine if cigarettes are being used in this manner by individuals with SP to reduce anxiety in anticipation of social situations or in response to stress associated with these situations. Considering the long-term consequences of cigarette smoking, it is important to get a clear understanding of the functional relationship between cigarette smoking and SP in order to create targeted interventions and cessation programs in the future for individuals with SP. Towards this end, the proposed study examines the relationship between level of SP (high SP, healthy control with average SP) and cigarette smoking-related outcomes (smoking topography, cigarette craving, relative reinforcement efficacy (RRE) of a cigarette) as a function of induced social stress (neutral, stress). Additionally, the current study examines negative reinforcement expectancies (NREs) as a moderator of the relationship between SP and smoking outcomes.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cigarette smoking is the leading preventable cause of death and disability in the United States. Identifying factors that contribute to cigarette smoking, such as comorbid psychopathology, represents the first step toward creating targeted interventions and cessation programs. The current project aims to examine the influence of Social Phobia (SP) on cigarette smoking (as measured by smoking topography and behavioral measures of the relative reinforcement efficacy of a cigarette) to experimentally explore whether cigarette smoking serves a functional role for individuals with SP. __SpecificAimsTextDelimiter__ Specific Aims Cigarette smoking is a prevalent, deadly, and costly behavior for which effective prevention and treatment programs are lacking (CDC, 2008a, 2008b, 2009). To form a clear understanding of the behavior of cigarette smoking, targeting high risk groups, or those that have elevated rates of cigarette smoking, is important. Rates of cigarette smoking are particularly elevated among individuals with psychopathology (CDC, 2008a). Within this broad category, individuals with Social Phobia (SP) represent a large group with elevated rates of cigarette smoking who quit smoking at rates lower than that of individuals without psychopathology (Lasser et al., 2000; Ruscio et al., 2008). These findings highlight cigarette smokers with SP as a particularly important group for further examination. Two existing prospective longitudinal studies suggest that a relationship between SP and cigarette smoking exists and that this relationship may be temporal in nature such that SP and SP symptoms predict the onset of nicotine dependence (Breslau, Novak, & Kessler, 2004; Sonntag et al., 2000). Despite this relationship, no studies to date have experimentally examined the functional relationship between SP symptoms and cigarette smoking. Thus, despite knowledge of this correlational relationship and the presence of strong theory to suggest a functional relationship, research provides little guidance to determine if cigarettes are being used in this manner by individuals with SP to reduce anxiety in anticipation of social situations or in response to stress associated with these situations. While little research exists examining the functional relationship between SP and cigarette smoking, negative reinforcement models of addictive behavior suggest that a functional relationship would exist between SP and cigarette smoking. Negative reinforcement models of cigarette smoking suggest that the motivational basis of addictive drug use is the reduction or avoidance of aversive internal states (Kassel, Stroud, & Paronis, 2003; Baker et al., 2004). This process is particularly relevant for SP considering increased feelings of anxiety in response to social situations and the need to regulate this anxiety. Along these lines, expectancies of negative affect reduction, or negative reinforcement expectancies (NRE) may be particularly relevant for individuals with SP. Among the general population of individuals who smoke cigarettes, NRE have been related to various negative affective traits as well as less success in quitting smoking (Wetter et al., 1994; Johnson et al., 2008; Schleicher et al., 2009). Furthermore, NRE may be particularly relevant when considering social situations and beliefs of how smoking a cigarette may alter feelings and behavior in response to social situations. Considering the long-term consequences of cigarette smoking, it is important to obtain a clear understanding of the functional relationship between cigarette smoking and SP in order to create targeted interventions and cessation programs in the future for individuals with SP. The purpose of the present study is: (a) to determine whether differences across SP group (high SP, healthy control with average SP) in cigarette smoking outcomes (smoking topography, cigarette craving, relative reinforcement efficacy (RRE) of a cigarette) are observed but only under conditions of social stress and (b) the extent to which differences in smoking outcomes as a function of social stress are attributable to NRE. A.1. Primary Aim. To examine group differences (high SP, average SP) in response to two conditions (neutral, social stress) among individuals who smoke cigarettes. A.1.a. Hypothesis. In response to a social stressor, smokers who are high in SP, compared to individuals who are average in SP, will have greater smoking outcomes evidenced by higher puff duration and puff intensity and shorter interpuff interval during smoking topography measures, higher levels of craving, and higher RRE of a cigarette. This difference will be evident within the high SP group compared to a neutral condition and between groups in the stressor condition, with no differences between groups in the neutral condition (see Primary Aim Expected Results below). A.2. Secondary Aim: To examine NRE as a moderator of the relationship between SP and smoking outcomes. A.2.a Hypothesis: The relationship between SP group and smoking-related outcomes will vary as a function of NRE. Individuals who are high in SP, compared to individuals who are average in SP, will exhibit significantly higher smoking outcomes as evidenced by higher puff duration and puff intensity and shorter interpuff interval during smoking topography measures, higher levels of craving, and higher RRE of a cigarette during the social stressor task as compared to the neutral task, but only for those who are also high in NRE (see Secondary Aim Expected Results below). A.1. Primary Aim Expected Results A.2. Secondary Aim Expected Results